National Eye Institute Media and Scientific Information Dissemination

The purpose of this task is to provide media services for activities related to reporting research results and other NEI dissemination activities.